Development of Localized Triple-Negative Breast Cancer Immunotherapy

ABSTRACT
Immunotherapy has revolutionized the way cancer is treated. However, limitations in efficacy combined
with immune-related toxicities following systemic administration of immunotherapy motivate the development of
safer, more effective approaches. Interest in intratumoral delivery of immunotherapeutics has increased in recent
years. Intratumoral or intralesional injections have the potential to maximize the delivery of immunotherapies
within the tumor while alleviating toxicities associated with traditional systemic delivery of broadly activating
immunotherapies. Unfortunately, the feasibility and efficiency of intratumoral injections are grossly
overestimated. Even with image-guidance, intratumoral injections often miss a targeted tumor and/or injected
contents quickly leak out of a tumor due to high hydrostatic pressures. Viscoelastic hydrogels can resist shear
forces that typically expel saline-based solutions from tumors after an injection. Formulating immunotherapeutics
within hydrogels, therefore, may improve retention and overall exposure to immunotherapy within an injected
lesion. Our preliminary and published data demonstrate that a novel injectable, imageable, biocompatible
hydrogel, called XCSgel, can increase the retention of co-formulated immunotherapies leading to profound
increases in antitumor activity. Specifically, interleukin-12 (IL-12) formulated in XCSgel (XCSgel-IL12) is retained
within an injected tumor for up to 4 weeks and can safely eliminate the majority of injected and uninjected distal
breast tumors. XCSgel is tunable through manipulation of several parameters, leading to multiple variations with
different mechanical properties, degradation rates, release kinetics, etc. It is not obvious which type of XCSgel
would maximize the antitumor potential of IL-12. Thus, it is important to optimize XCSgel-IL-12 prior to clinical
translation. The overarching goal of this proposed Phase I STTR project is to identify and de-risk a lead XCSgel-
IL12 candidate with demonstrated efficacy and safety profiles in stringent murine TNBC models. Aim 1 will focus
on synthesizing, characterizing, and optimizing XCSgel-IL12 in a rigorous downselect process from twelve
potential candidates to three. Aim 2 will evaluate the pharmacokinetics/pharmacodynamics, safety and
toxicology of the top three XCSgel-IL12 candidates. Although localized XCSgel-IL12 immunotherapy may be
effective in controlling a range of solid malignancies, this project will focus on triple-negative breast cancer
(TNBC) as an initial indication. TNBC is an aggressive subtype of breast cancer that requires debilitating and
toxic treatments and yet suffers from unacceptably high recurrence rates.

Public health relevance
PROJECT NARRATIVE XCSgel is a novel, injectable hydrogel capable of enhancing the retention and efficacy of co-formulated immunotherapies after direct injections into a tumor. Building on promising preclinical data, this project will synthesize and evaluate twelve candidates of XCSgel co-formulated with the immunotherapeutic interleukin-12. An optimal immunotherapy for triple-negative breast cancer, based on antitumor activity and safety, will be identified and advanced towards clinical translation.